Alzheimer's Disease Organelle Proteome Task (ADOPT)-pilot phase

PROJECT SUMMARY
Dysfunctions in organelles such as the mitochondria and lysosomes are increasingly being appreciated to
drive various forms of neurodegenerative diseases, such as the Alzheimer's disease and Alzheimer's
disease-related dementias (AD/ADRD). However, an integrated organelle proteome consortium in the field
of AD/ADRD is lacking. To address this knowledge gap, an interdisciplinary team, consisting of Drs. Biao
Wang and Danielle Swaney will form the Alzheimer's Disease Organelle Proteome Task (ADOPT), to
quantitatively measure organelle proteome to provide in-depth knowledge of organelle homeostasis and
function in the complex brain tissues during the disease progression of AD.
This R03 proposal is a pilot phase of ADOPT, in which genetic organelle tagging approach will be utilized
to enable rapid purification of lysosome from neurons in wild-type and AD brains from mouse models. A
suite of mass spectrometry experiments will quantitatively measure organelle proteome, including protein
abundance, post-translational modifications, and protein complexes. Computational modeling will
determine lysosomal proteome homeostasis. This systems-to-function approach will shape new scientific
paradigms in AD/ADRD research.

Public health relevance
PROJECT NARRATIVE The “organelle proteomics” is an emerging concept, bringing new frontiers to biomedical research. This proposal aims to measure lysosomal proteome in a mouse Alzheimer's disease model, with an ultimate goal of building an integrated organelle proteome consortium and enabling hypothesis-driven research to find new treatments for the Alzheimer's disease and Alzheimer's disease-related dementias (AD/ADRD).